UW Radiological Sciences Training Program

Project Summary:
This training program prepares eight predoctoral graduate students and three postdoctoral researchers for
careers in the application of physics to the medical diagnosis and treatment of cancer. Available research
specializations encompass broad areas of physics as applied to disease diagnosis, patient-specific treatment
and assessment of treatment efficacy, and basic physics research applied to cancer. The 34 mentors and 17
other Participating Faculty in the Departments of Medical Physics, Radiology, Human Oncology (Radiation
Oncology), Engineering Physics, and Biomedical Engineering maintain a broad spectrum of research
collaborations with other clinical and basic science researchers. Translational, team-driven research includes
traditional x-ray, CT, MRI, ultrasound, and PET imaging with the Department of Radiology, and radiation
physics, radiation biology, and radiation therapy with the Departments of Physics, Nuclear Engineering, and
Human Oncology. Trainees are intimate participants in these research programs as collaborators, publishing
joint research articles, and performing as investigators in extramurally funded grants and contracts. Extensive
faculty contact provides leadership and supervision. Beyond research activities, predoctoral trainees as
graduate students in Medical Physics take at least twenty-six credits supportive of medical physics training and
oriented towards their research specialization. Nominees for predoctoral positions in this training program
typically have passed their preliminary examination of a proposed PhD research plan related to cancer. This
significantly increases the likelihood of their remaining in cancer-related research and shortens their typical
time in the NRSA position to about two years. Postdoctoral trainees are encouraged to broaden and deepen
their academic training by auditing appropriate courses, and their appointments are typically 2-3 years. Both
predoctoral and postdoctoral trainees must take or audit additional research ethics courses, cancer-specific
courses, must attend relevant grand round presentations, and must participate in intensive workshops on
manuscript writing and grant writing. Trainees give seminars, attend colloquia, present research results at
local, national, and international meetings, and co-author articles and reports. An annual Training Grant
Symposium provides additional opportunity for trainees to present research results to the Medical Physics and
collaborating faculty. In this way trainees in this program are well prepared to assume leadership positions as
researchers and academicians in the application of physics to cancer prevention, diagnosis, and treatment.

Public health relevance
Project Narrative: This training program prepares graduate students and postdoctoral trainees in radiological sciences for careers in cancer research. Researchers in this field continue to have a high impact on the diagnosis and treatment of cancer, leading to major advances particularly in the areas of medical imaging, image guided intervention and radiation therapy.